Stimulating Access to Research in the University of Cincinnati Internal Medicine Residency Program

The number of physician scientists, in both adult and pediatric medicine, is declining despite an overall
increase the total number of physicians. Without a substantial increase the pool of early stage physicians
interested in embarking on a research career, the shortfall of successful physician scientists will worsen.
Although the reasons are complex and are in part because of the increasing challenge of sustaining a successful
research career, an identified and possibly remediable cause is the high attrition rate of potential research
capable physicians at the residency stage of training. We now propose a University of Cincinnati (UC)-StARR
program focused on identifying internal medicine residents with an interest in a research career. Once identified,
we will mentor them through a flexible combined didactic and research experience that places them in a
competitive position to pursue a successful physician-scientist career. The overall goal is to increase the pipeline
of internal residents earmarked for research-oriented academic careers. We will complement programs that we
already have in place at that are primarily focused on fellowship level training.
We propose the following: 1) establish a cadre of well-funded NHLBI investigators from the University of
Cincinnati College of Medicine and Cincinnati Children’s Hospital Medical Center experienced in training
physician scientists in standard disciplines and peds-to-adult transition medicine, 2) recruit high quality resident-
investigators from of a pool of qualified and diverse candidates within our internal medicine residency program,
3) implement a unique curriculum that caters to the residents’ different prior experience to complement our
existing programs; this will include online courses and a three month elective/workshop during the first half of
PGY2 year followed by formal course work during PGY3 year that concludes with a dedicated Research Block
during the PGY3 year, and 4) implement an individualized resident-investigator development plan and then
evaluate and ensure success by engaging in a validated, state-of-the-art, and real time learning based online
evaluation system.
In summary, UC-StARR will build upon existing programmatic infrastructure to that brings together 18
experienced, well-funded mentors within the fields of cardiovascular, pulmonary and critical care medicine. The
proposal is innovative because we are coupling this not only with our validated and nationally recognized system
that enhances resident learning and tracks outcomes but also with our existing largely fellow-focused research
investments. The combination of catering to the special needs of residents and training them in a logical
sequence on the principles of research is likely to have a significant impact on increasing the number of Internal
Medicine physician-scientists being trained at UC. We would expect that this model, if further validated, could
serve as readily implemented template for other Internal Medicine residency programs.

Public health relevance
Without a substantial increase the pool of early stage physicians interested in embarking on a research career, the shortfall of successful physician scientists will continue to worsen. We propose to address this challenge by instituting a program, University of Cincinnati-StARR, that provides internal medicine residents interested in a research career with the research tools available at UC as well as Cincinnati Children’s (CCHMC) to then transition to academic fellowships and a successful physician scientist career. This will complement an infrastructure that is already in place at that has focused more on enhancing academic fellowship training.